Conjugate vaccine impact on pneumococcal carriage, disease, and population geneti

DESCRIPTION (provided by applicant): This competing renewal application builds on the success and productivity of our current project investigating changes in the pneumococcal population in the conjugate vaccine era, and seeks to continue surveillance and analysis during the introduction of PCV13. Our work to date has substantially increased our understanding of how this pathogen responds to the potent selective pressure of a vaccine. As PCV7 vaccine serotypes have virtually disappeared from the nasopharynx, they have been quickly and completely replaced by non-vaccine serotypes. Clinically, these non-vaccine serotypes have become responsible for the great majority of invasive pneumococcal disease. Now, a new 13-valent pneumococcal conjugate vaccine (PCV13) that includes 6 additional serotypes (1, 3, 5, 6A, 7F, 19A), will be introduced in 2010. This research will provide data needed to understand the clinical implications of PCV13 use, test specific hypotheses we have developed about bacterial adaptation, and serve as a template for understanding the evolution of other pathogens. Given our team of collaborators, the ongoing commitment of community partners, and our access to state-of-the-art genetic sequencing resources, we are uniquely positioned to address the following specific aims: 1. To examine trends in pneumococcal colonizing and invasive disease isolates, with regard to serotype and antibiotic resistance, host risk factors, and invasive potential, before and after introduction of PCV13. 2. To assess shifts in pneumococcal population structure (by MLST) and evaluate potential factors associated with successful spread of pneumococcal clones in Massachusetts in the context of PCV13 introduction. 3. To use whole genome sequencing to identify potential genetic determinants associated with serotype switching and invasiveness among clones that have emerged under selective vaccine pressure. To achieve these goals, we will collect new nasopharyngeal specimens from 2,250 children as they present for routine pediatric care (in 2011 and 2014) in nine distinct Massachusetts communities, and analyze them in the context of previous collections available for comparison from 2001, 2004, 2007, and 2009. In addition we will simultaneously analyze invasive disease isolates collected from children in Massachusetts as part of an enhanced statewide surveillance program in Massachusetts since 2001. In total, this continuing project provides an unprecedented opportunity to assess bacterial evolution in real time, and connect changes in carriage to those in invasive disease.

Public health relevance
PUBLIC HEALTH RELEVANCE: Relevance The introduction of PCV13 will allow us to test specific hypotheses about the sequence and mechanisms of bacterial evolution in response to the potent selective pressure of immunization and continuing pressure of high rates of antibiotic use. Specifically, we will better understand the roles of antibiotic resistance, and other specific adaptations (e.g. the presence of pilus), as well as the clinical implications (for invasive disease) of inclusion of 19A, currently the most invasive and rapidly expanding serotype. These results will inform development and implementation of future vaccines, for pneumococcus and other organisms, by providing data on possible responses of bacterial populations that may blunt their intended clinical impact. Relevance The introduction of PCV13 will allow us to test specific hypotheses about the sequence and mechanisms of bacterial evolution in response to the potent selective pressure of immunization and continuing pressure of high rates of antibiotic use. Specifically, we will better understand the roles of antibiotic resistance, and other specific adaptations (e.g. the presence of pilus), as well as the clinical implications (for invasive disease) of inclusion of 19A, currently the most invasive and rapidly expanding serotype. These results will inform development and implementation of future vaccines, for pneumococcus and other organisms, by providing data on possible responses of bacterial populations that may blunt their intended clinical impact. __SpecificAimsTextDelimiter__ 2. Specific Aims In 2000, a heptavalent pneumococcal conjugate vaccine (PCV7) for young children was introduced in the U.S., resulting in a substantial decline in invasive pneumococcal disease among both vaccinated and unvaccinated individuals. Since that time, this group of investigators, with expertise in clinical infectious diseases, epidemiology and pneumococcal population genetics, has worked collaboratively to evaluate many of the critical changes in the pneumococcal reservoir in the community by serially sampling pneumococcal carriage in healthy children residing in eight communities in Massachusetts (NIAID R01 AI066304). We now propose continuation and expansion of this work through this competitive renewal which leverages new access to data regarding concurrently collected invasive isolates, adds an additional sampling site with high proportions of urban and minority children, and makes use of new collaborations for selective whole genome sequencing to address previously unanswerable questions about predictors of clonal success. This proposal seeks funding that will allow further genetic analysis of both colonizing and invasive isolates from 2001 to the present (already in hand), as well as newly collected carriage and invasive specimens through 2014. Such longitudinal analysis of carriage and invasive disease in a stable geographic population of children is both unprecedented and timely, given the impending introduction of PCV13, another selective pressure on this pathogen. This proposal builds on the success of our current project elucidating the dramatic changes in the pneumococcal population in the conjugate vaccine era. These contributions have substantially increased our understanding of how this pathogen and others respond to the potent selective pressure of a vaccine. We, and others, have documented that as vaccine serotypes (4, 6B, 9V, 14, 18C, 19F, 23F) virtually disappeared from the nasopharynx, they were quickly and completely replaced by non-vaccine serotypes. The clinical impact has been that non-vaccine serotypes have become responsible for the great majority of invasive pneumococcal disease.1 For example, serotype 19A, which is not included in PCV7, is now the predominant serotype responsible for invasive pneumococcal disease among children in Massachusetts and the U.S.2,3 However, the story of rapid pneumococcal evolution is not over. A new 13-valent pneumococcal conjugate vaccine (PCV13) that includes 6 additional serotypes (1, 3, 5, 6A, 7F, 19A), including those that have emerged as a cause of invasive disease since the introduction of PCV7, is currently being considered for FDA licensure, with approval anticipated to occur by the end of 2009.(CDC_ACIP presentation avail at: www.cdc.gov/vaccines/recs/acip/downloads/mtg-slides-jun09/17-3-pneu.pdf) While use of PCV13 has the potential to further reduce the burden of invasive disease, studying the evolution of pneumococcus in response to selective pressures from PCV13 will have important clinical implications, even as it continues to teach us more about bacterial population biology, generally. This research will provide critical data needed to understand the clinical and policy implications of PCV13 use and serve as a template for understanding the evolution of pathogens with significant disease-causing potential. Given our team of collaborators, the ongoing commitment of community partners, and our access to state-of- the-art genetic sequencing resources, we are uniquely positioned to address the following specific aims: 1. To examine trends in pneumococcal colonizing and invasive disease isolates, with regard to serotype and antibiotic resistance, host risk factors, and invasive potential, before and after introduction of PCV13. 2. To assess shifts in pneumococcal population structure (by MLST) and evaluate potential factors associated with successful spread of pneumococcal clones in Massachusetts in the context of PCV13 introduction. 3. To use whole genome sequencing to identify potential genetic determinants associated with serotype switching and invasiveness among clones that have emerged under selective vaccine pressure.